DEVELOPMENT AND EVALUATION OF COMMUNITY ASTHMA PROGRAM

Asthma prevalence and mortality among Black children exceed levels among whites. Asthma management programs have reduced symptoms, attacks and emergency room usage. However, a pattern of underutilization and neglect of care among Black Americans in cases of asthma deaths among Black children indicate the importance of promoting ongoing versus episodic care, reduced exposure to triggers, sensitivity to signs of attacks, attack management, and communication with caregivers, professionals, and teachers. Research in Black communities indicates the importance of informal networks and neighborhood influences, in promoting improved asthma care within low-income Black communities. We propose to evaluate a community organization approach to promoting asthma management in 4 neighborhoods in St. Louis with predominantly low income, Black populations. Working with an established community agency, Grace Hill Neighborhood Services and its Community Wellness Board, we shall establish Neighborhood Steering Committees to oversee development and implementation of a Neighborhood Asthma Collaboration (NAC) in each neighborhood. The 36-month NAC will include (a) promotional campaigns to increase awareness of asthma and its care; (b) Neighborhood Volunteers disseminating leaflets encouraging identification of and continuing care for asthma, and recruiting participants into NAC programs; (c) Neighborhood Volunteers trained as Asthma Advocates to work with asthmatic children and their cares--rivers to encourage asthma co-management and to conduct management programs in local institutions; (d) an Asthma Management Course offered through community health centers, churches, and other local institutions; and, (e) local school programs including in-service teacher education on asthma management, an asthma program for all students to enhance support for asthmatic children, and school implementation of the Asthma Management Course. Prior to implementing the NAC, we will (a) review, adopt, pilot and revise existing asthma management educational and promotional materials, (b) work with asthma care providers to gain their involvement in program planning and patient referral to the NAC and (c) adapt from other worksite/community health promotion programs we have developed, procedures for working with Neighborhood Steering Committees and training Neighborhood Volunteers. General evaluation will include (a) surveys of community awareness of and attitudes toward asthma, (b) dissemination and implementation, and (c) pre-post changes in symptoms, attacks, ER visits, and hospitalizations among all child participants in the NAC. These measures as well as kept appointments and serum theophylline levels less than or equal to 5 mg/dl will be used in two controlled studies within the NAC to compare (1) children from study neighborhoods with children from socioeconomically comparable neighborhoods, all of whom receive care through Children's Hospital of Washington University, and (2) children receiving care through two Centers serving other, socieoeconomically similar neighborhoods.